CELLULAR AND MOLECULAR IMAGING CORE

The Cellular and Molecular Imaging Core, which had its origin in 1977, facilitates the outstanding and
innovative research of Diabetes Research Center affiliates in the Seattle area by keeping pace with and
pioneering new methodological and technical advances in (immuno)histochemistry, microscopic imaging and
image analysis. In the next funding cycle the CMIC will continue to promote the research of these investigators
by providing: (1) Expert diabetes-related technical and scientific support, including consultation for study
design, use of appropriate controls, and interpretation of results; (2) Rigorous quantitative assessment of
immunohistochemistry and morphological changes in tissues; (3) Cost-effective access to state-of-the-art
imaging instrumentation; (4) Hands-on and didactic training to affiliates, their trainees, and personnel with
routine and highly specialized morphological, histochemical, and imaging techniques; and (5) Access to clinical
and comparative pathologists to assist with experimental and/or preclinical studies. Through all of these
services, Core leadership and staff share their deep expertise in working with diabetes-relevant tissues and in
interpreting disease-related changes in cellular composition/morphology. The Cellular and Molecular Imaging
Core places a great deal of emphasis on ensuring high standards of rigor and reproducibility for studies
undertaken in the Core. This includes, but is not limited to, rigorous quality control for reagents, expert review
of protocols and ensuring appropriate and adequate use of positive and negative controls. The Core offers
multiple state-of-the-art services for automated immunohistochemistry, conventional, confocal and super-
resolution microscopy, laser capture microdissection and automated/AI image analysis. By achieving these
goals, the Cellular and Molecular Imaging Core will continue to support the scientific investigation of affiliate
investigators who will use the Core to further our understanding of diabetes and related disorders.